NeuroAccess: a Focused Ultrasound System for SonoBiopsy of the Brain

PROJECT SUMMARY
Cordance Medical aims to address an unmet critical need in the management of brain tumor patients through
the development of the NeuroAccess™ system. This focused ultrasound device is designed for safe, temporary,
and non-invasive blood-brain barrier (BBB) opening, enabling a novel liquid biopsy technique termed
SonoBiopsy™. The major obstacle to the widespread clinical adoption of liquid biopsies for brain tumors is the
BBB, which restricts the passage of circulating free DNA (cfDNA) from the brain tumor into the bloodstream. The
long-term goal is to transform the clinical management of malignant brain tumor patients by providing timely
and critical molecular information for therapy selection, monitoring disease progression, and aiding in the
differentiation between true progression and pseudo-progression. The overall objective of the proposed FDA-
clearance clinical trial is to demonstrate the safety and efficacy of SonoBiopsy using the NeuroAccess system.
We will recruit 70 patients with either recurrent primary brain tumors, such as glioblastoma (GBM), or new brain
metastases.
We have strong preliminary data that demonstrates the device's safety and precision in BBB opening through
rigorous pre-clinical testing and evaluation in large animal models. Two specific aims guide the trial: 1) To
demonstrate the safety and efficacy of SonoBiopsy in primary brain tumors by achieving safe BBB opening and
significantly increasing cfDNA concentrations above the limit-of-detection of 10ng/ml; and 2) To validate the
technique in secondary brain tumors by detecting novel or private mutations in at least 20% of the SonoBiopsy
specimens compared to baseline, using truncal genomics to confirm specificity. This project is innovative
because it offers a non-invasive, cost-effective, and community-centric solution, setting the stage for widespread
adoption of SonoBiopsy. The proposed research is significant because it has the potential to catalyze the
accumulation of translational SonoBiopsy knowledge and ultimately advance the diagnosis and treatment of
brain tumors. The project aligns with Cordance Medical's mission to develop innovative solutions for neurologic
diseases and is backed by a seasoned team of medical device leaders. Recognizing the importance of the
regulatory path, Cordance Medical has obtained an FDA Breakthrough Device Designation for this
application and has been enrolled into FDA TAP in alignment with obtaining a Class II clearance. By
enabling the regular acquisition of tumor genetic and molecular signatures without the need for invasive
procedures, the NeuroAccess system stands to substantially improve brain tumor management across various
healthcare settings.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it aims to develop a non-invasive ultrasound device to assist in diagnosing and monitoring brain tumors. By safely and temporarily opening the blood-brain barrier, the device can enhance personalized care for patients with malignant brain tumors. This advancement has the potential to revolutionize brain tumor management by providing regular insights into tumor genetics and molecular changes, ultimately aiming to improve patient outcomes and quality of life.